EFFECTS OF SODIUM ON BONE METABOLISM

Effects of sodium on bone metabolism can be profound, especially in individuals with preexisting low calcium intakes. This study will test the hypothesis that there are differences between African-American and Caucasian postmenopausal women with osteopenia and normal bone density with respect to calcitropic hormones and bone metabolism markers in response to a sodium challenge."